IGF::OT::IGF AWARD FOR SBIR PHASE I, TOPIC 154, N43DA-14-1208: XDA - EXPERIMENTAL DESIGN ASSISTANT, POP: 08/01/2014 - 07/31/2015.

Under this Small Business Innovation Research (SBIR) Phase I project, Research Topic 154 for XDA- eXperimental Design Assistant the contractor will develop a bi-modular bundle to assist addiction and other life science investigators in designing in vivo animal experiments .